Center for Live Cell Genomics

ABSTRACT
Center for Live Cell Genomics
We will build new methodology and capacity for large-scale, long-term, inexpensive, modular,
customizable, shared, Internet-of-Things-controlled, reproducible live cell culture and tissue-based
experimental genomics disease models. Tissue models include traditional cell culture as well as
organoid and primary tissue explants obtained from surgery or biopsy. Organoid factories supporting
tissue growth and maintenance will be integrated with external and on-chip electro-optofluidic analytical
modules to become part of an ecosystem that is modeled after open-source software. It will use
commodity sensors, cameras, and computers linked in platforms flexibly designed using simple 3D
printing, molding, etching and milling techniques potentially available at any institution. This will
stimulate rapid innovation in experimental platforms for tissue culture.
We will push this technology and use its best-in-class capabilities to make progress in
neurodevelopment and pediatric cancer, addressing big questions. What genes contribute most
importantly and specifically to human brain development? How do they go wrong in
neurodevelopmental disease or brain injury? What specific molecular pathways are disrupted in
individual pediatric cancer cases? How can we test pathway-specific treatments in a tissue model
specific to each patient?
Our education and outreach plans include a training program to develop a diverse and inclusive cohort
of undergraduate students trained in genomic science through secondary school and community
college outreach as well as coding workshops and research-based laboratory classes for UCSC
undergraduates to develop core competencies. Participation in these activities serve as a basis for
training graduate students and postdocs in inclusive pedagogy and mentorship. We are also developing
a one-stop information hub to form an online community and to share our technology through
immersive webinars and tutorials aimed at a broader audience with a range of expertise from the
general public to scientists and clinicians at research institutions.
Our work will enable significant advances in neuroscience and cancer research and education,
stimulate a new open-source culture in cell biology and genomics, and democratize scientific and
educational access beyond elite institutions, extending sharing projects like NHGRI ANvIL beyond data
and code to include experiments and Internet-connected experimental platforms.

Public health relevance
Project Narrative We will introduce a new experimental platform paradigm to genomic studies of live cells and tissues that will allow scientists to be more creative, more productive, more collaborative and use fewer resources for their live cell genomics experiments. We will create new platforms that provide living cells growing in realistic 3D cultures that mimic actual tissues in the body and incorporate Internet-based remote control and analysis capabilities. We will deploy this technology to perform new, more robust and more reproducible experiments leading to discoveries in neurodevelopmental disease and cancer.